EFFECT OF NUTRIENT INTAKE ON ACUTE TOBACCO WITHDRAWAL

To determine whether individuals undergoing acute withdrawal from nicotine experience improvement of mood after consumption of a carbohydrate rich food. The results, if positive, will be used as the basis for the development of food plans for people going through smoking withdrawal.